Enhancing CAR T therapy in multiple myeloma

SUMMARY OF WORK
Our long-term goal is to develop novel approaches to enhance the efficacy of chimeric antigen receptor (CAR) T
therapy. CAR T cell therapy targeting B-cell maturation antigen (BCMA) has shown great promise in the treatment
of relapsed and/or refractory (RR) multiple myeloma (MM). However, even with relatively short follow-up relapse
eventually occurs in over half of all patients with a median progression-free survival of only 11.8 months (Raje et
al. N Engl J Med 2019; 380:1726). A better understanding of the mechanisms of myeloma relapse and resistance
to CAR T therapy is urgently needed and will lead to improved CAR T therapy. Myeloid-derived suppressor cells
(MDSCs) are a heterogeneous population of cells consisting of monocytic MDSCs and granulocytic MDSCs.
MDSCs inhibit T cell function and are thought to play an important role in CAR T therapy resistance/relapse. The
addition of MDSC depleting therapy increases CAR T efficacy in solid tumor models (Long et al. Cancer Immunol
Res 2016; 4:869). Recently we have found that patients with RRMM had significantly elevated Gr-MDSCs.
Additionally, we found that an increase of MDSCs correlated with the development of MM in a transplantable
VK*MYC mouse myeloma model. Interestingly, compared to wild-type or sphingosine kinase 1 (SK1) knockout
mice, sphingosine kinase 2 (SK2) knockout mice were completely free of myeloma after being injected with
VK*MYC myeloma cells and showed significantly reduced numbers of MDSCs. Furthermore, treatment with a
specific SK2 inhibitor (ABC294640, YELIVAÒ) eliminated both human and mouse MDSCs. ABC294640 showed
an excellent safety profile in our recently completed phase I study in patients with RRMM (NCT02757326). The
objective of this application is to determine the efficacy of combining SK2 inhibition with CAR T therapy in the
treatment of MM. Our central hypothesis is that the combination of SK2 inhibitor and CAR T therapy will enhance
the response and duration of the CAR T therapy by reducing the number of MDSCs. We have three specific aims.
Aim 1 is to determine the efficacy of the combination of SK2 inhibitor (ABC294640) and CAR T therapy in vivo in
a fully immunocompetent, syngeneic myeloma CAR T therapy mouse model. We will determine the efficacy of
combining ABC294640 with mouse BCMA-targeted CAR T cell therapy in vivo. Aim 2 is to determine the
mechanisms through which SK2 regulates MDSCs. We will determine the effects of SK2 on MDSC differentiation
and function and on the S1P-STAT3/HDAC-1/2- ROR-gt pathway. Aim 3 is to measure the number and function
of MDSCs over time in hematologic malignancy patients treated with CAR T therapy and determine the correlation
between MDSCs and disease relapse/resistance to CAR T therapy. Our research is innovative, because it
represents a new and substantive departure and significant advance from the status quo by understanding the
roles of MDSCs and SK2 in CAR T therapy. Our study will fundamentally advance our knowledge of CAR T
resistance and relapse, and have a positive translational impact on the care and outcomes of patients with MM.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health. Multiple myeloma is the second most common hematological malignancy in the USA. Developing safe and more effective treatment is expected to improve the outcomes of patients with multiple myeloma. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to developing fundamental knowledge that will help to reduce the burdens of human disability.